Medical Scientist Training Program

Project Summary/ Abstract UIC
At a time when new foundational scientific knowledge is rapidly increasing, there is an urgent need to continue
investing in nurturing the next generation of physician-scientists capable of generating and translating that
knowledge to the bedside care of patients. Clinician-scientists have bridged the translational gap between
fundamental new knowledge in the pathobiology of disease and advances in health care. To continue
developing a diverse pool of well-trained physician-scientists with the skills to conduct rigorous scientific
research and engage in clinical practice, the University of Illinois at Chicago (UIC) Medical Scientist Training
Program (MSTP) offers a program of combined MD and PhD training. Our dual-degree program, established in
2003, has been NIH-funded for over 15 years. The central goal of the UIC MSTP is to train the next generation
of clinician-scientists to create new knowledge and implement evidence-based medicine by incorporating
didactic, rigorous research, mentoring and career development plans. A key component of our program is the
tremendous benefit provided by the diversity of trainees and mentors, which is aligned with UIC’s long-standing
dedication and leadership in fostering diversity, equity, and inclusion in all its educational programs. Thus, the
major objectives of the UIC MSTP are to provide a well-integrated training program that equips trainees from
diverse backgrounds to become leaders in medicine, to elucidate the mechanisms of disease at molecular and
cellular disease level using ‘omics’ technologies, whole animal, clinical, and translational approaches to
biomedical research. Our students will learn in an environment that addresses challenges and will be trained to
translate this new knowledge into best evidence-based care of patients. The mentors are highly successful
clinician-scientists/scientists with a proven track-record of research, mentoring, and collaboration who offer
superb inter- and multi-disciplinary training opportunities. We are highly diverse and balanced national
academic progress of excellence. Currently 102 individuals, from all over the country, are enrolled in the
program with our holistic mission-based selection process enabling us to enrolled 53% women and 22% URMs
with five-year average entering metrics of 3.7 GPA and 514 MCAT with a matriculation rate of 4% from a five-
year applicant pool average of 318. Our current MSTP students include 22 under-represented minority (URM)
and 34% disadvantaged/disabled trainees. The average time to complete a dual MD and PhD is 8.0 years and
our students have matched at the most competitive residency programs. Several important and exciting
advances have recently been implemented including design and implementation of new mentoring program
with the creation of an advising house system and pairing trainees in the final year of PhD studies with
clinician-scientists; a new Graduate Education in bioMedical Sciences (GEMS) program with thematic
interdisciplinary tracks; a diversity of research experience with increasing numbers of students pursuing non-
traditional PhDs; systematic training of mentors on core competencies; design and implementation of a
comprehensive program evaluation that creates mechanisms for continual feedback on advising, educational,
and administrative processes; and enhancing the diversity of student recruitment through a three-tiered
approach. We are confident that our program will continue to successfully train the next generation of
physician-scientists. Towards this goal, we are requesting support for 10 positions.

Public health relevance
Project Narrative This program produces physician scientists who have both MD and PhD training, i.e., who receive both degrees at the completion of the program. MD-PhD graduates have deeper perceptions of medical significance in biology than do scientists without medical education, more comprehensive understanding of the limitations in medical practice, and greater ability to transfer basic scientific advances toward patient care advances. Thus, MD-PhD graduates are positioned to identify and pursue interdisciplinary approaches to important biomedical problems, and to help bridge the basic and clinical sciences.